Imaging the Neurochemistry of Binge-Drinking in College-Aged Young Adults

DESCRIPTION (provided by applicant): Recent reports show that young-adult binge drinking has become a major public health problem. Nevertheless, the neurochemistry associated with this type of alcohol misuse has not been extensively studied. Previous radiotracer imaging studies in alcohol dependence have reliably shown that this disorder is associated with a reduction in dopamine type 2/3 (D2/3) receptor binding in addition to a decrease in dopamine transmission of the ventral striatum. Studies in alcohol-preferring rodents show similar results. In addition, functional MRI studies have shown that alcohol dependence is associated with a loss of reward-related activation in the ventral striatum. The goal of this study is to measure these parameters of dopamine transmission in young- adult binge drinkers compared to control subjects. Using PET radioligand imaging, we will measure both D2/3 receptor binding in addition to changes in extracellular dopamine in response to a psychostimulant challenge. We will also image, for the first time in human subjects, the kappa receptor in vivo. Previous pre-clinical studies suggest that alcohol exposure is associated with an increase in endogenous dynorphin and a downregualtion of the kappa receptor. All subjects will also undergo an fMRI using the monetary incentive delay task, a task that is associated with decreased ventral striatal activation in alcohol dependence. We will also investigate the correlation between dopamine transmission measured with PET and activation measured with fMRI in the ventral striatum in the same subjects. In addition, this application will explore the correlations between the brain measures obtained, including the correlation between pre-synaptic dopamine function measured with PET and fMRI and the association between kappa receptor availability and dopamine transmission. It has previously been hypothesized that the decrease in dopamine transmission see in alcohol dependence is associated with a reward deficiency syndrome. A possible mechanism for this is dynorphin signaling at the kappa receptor. Thus, in this study, we have proposed a set of specific aims that are designed to measure dopamine transmission and reward-related activation with the hypothesis that disruptions in striatal dopamine transmission underlie excessive alcohol consumption in this vulnerable population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Previous studies have shown deficiencies in the brain neurotransmitter dopamine in alcohol dependence. This decrease in dopamine transmission is thought to play an important role in disruptions in normal reward processing. The goal of the present study is to investigate whether these alterations are present in young-adult binge drinkers, and to investigate potential mechanisms behind the disruptions in dopamine transmission. Previous studies have shown deficiencies in the brain neurotransmitter dopamine in alcohol dependence. This decrease in dopamine transmission is thought to play an important role in disruptions in normal reward processing. The goal of the present study is to investigate whether these alterations are present in young-adult binge drinkers, and to investigate potential mechanisms behind the disruptions in dopamine transmission. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Although excessive alcohol use in young adulthood is a persistent public health problem, few studies have investigated the neuroscience associated with this type of alcohol misuse. The National Survey on Drug Use and Health (NSDUH) has shown that that 23 to 32% of young adults (18-25) reported binge alcohol use in the last month [4] and a recent survey of college students reported that up to 40 percent of participants had engaged in binge drinking during the 2-week period preceding the survey [5]. Even though binge drinking is associated with an increased risk of future alcohol abuse and dependence [6, 7], very little is known about the neurobiology of binge drinking in this age group, and how it compares to the known alterations in neurochemistry seen in alcohol dependence. Improved understanding of the neurobiology of binge drinking and how this relates to the neurobiology of alcohol dependence may be crucial for understanding and preventing the transition from binge development to alcohol dependence. Thus, the goal of this application is to use Positron Emission Tomography (PET) to investigate the neurochemistry of binge drinking in young adults. The focus of this application is on dopamine transmission and kappa receptor binding in the striatum. Previous imaging studies have shown that alcohol dependence is associated with a significant disruption in striatal dopamine neurotransmission and pre-clinical studies suggest that the dynorphin/kappa receptor system plays an important role in excessive alcohol consumption. The specific aims of this proposal are: Specific Aim 1: We will test the hypothesis that dopamine type 2/3 (D2/3) receptors are decreased in young adult binge drinkers compared to matched control subjects, measured with PET and the radiotracer [11C]raclopride. Low D2/3 receptor binding has been shown in human studies of alcohol dependence [8, 9] using the same radiotracer. In animals, low D2/3 receptor binding has been shown to predict alcohol self-administration [10]. Conversely, high D2/3 receptor availability in humans may be protective against the development of alcoholism [11]. Together, these findings suggest that low D2/3 receptor availability is associated with a propensity to depend on pharmacological stimulation to experience reward and might serve as a risk factor for addictive behavior [12, 13]. Thus, an important step is to determine whether low D2/3 receptor binding occurs in college-aged young adults who misuse alcohol. Specific Aim 2: We will test the hypothesis that striatal dopamine release is reduced in the ventral striatum of young-adult binge drinkers compared to matched controls, using [11C]raclopride and a psychostimulant challenge. Two previous PET studies have shown that striatal dopamine release is blunted in alcohol dependent volunteers. One of these studies was performed by the PI of this application (please see results below) and the other was performed by Volkow et al [1]. Both studies [11C]raclopride and a psychostimulant challenge to measure striatal dopamine transmission, and both showed blunting in the ventral striatum. Thus, we will study this same neurochemistry in college-aged binge drinkers and test the hypothesis that dopamine transmission is reduced compared to control subjects. Specific Aim 3: We will test the hypothesis that young-adult binge drinkers will exhibit less striatal activation compared to control subjects using fMRI and a reward related task. In addition to imaging blunted dopamine release with PET, we will also investigate striatal dysfunction using functional MRI and the monetary incentive delay (MID) task to probe reward anticipation. Previous studies using this task and fMRI have demonstrated that alcohol dependence is associated with reduced activation in the left ventral striatum, right posterior putamen, and in the right head of the caudate nucleus during gain versus non-gain anticipation [14]. We will investigate this same neuropathology in binge drinkers using the same task. Specific Aim 4: Using PET and the kappa-receptor selective radiotracer [11C]GR103545, we will test the hypothesis that kappa receptor binding is reduced in college-aged binge alcohol drinkers compared to healthy control subjects. A number of pre-clinical studies have demonstrated that the propensity to self-administer ethanol is associated with alterations in dynorphin/kappa receptor neurotransmission [15]. Studies in rodents have shown a reduction in kappa receptor levels in the stratum of alcohol-preferring rodents [15], possibly in response to excess endogenous dynorphin levels [15]. The goal of this specific aim is to image, for the first time, kappa receptor binding in young adults who misuse alcohol, in order to investigate the relevance of this receptor system in this understudied disorder. Specific Aim 5: We will test the hypothesis that a family history of alcohol dependence is associated with an increase in D2/3 receptor binding compared to subjects without a family history. A previous study has shown that young adult social drinkers (non-alcohol abusing or dependent) subjects with a family history of alcohol dependence have higher D2/3 receptor binding compared to matched subjects without a family history of alcoholism in the ventral striatum and caudate [11]. We will seek to replicate this finding in this application in the non-binge drinkers. Thus, the overall goal of this study is to characterize the neurochemistry of alcohol misuse among young adults. In addition, we will investigate whether this neurochemistry is predictive of future alcohol abuse or dependence by following subjects for up to seven years after their participation (when all subjects will be over the age of 25). Exploratory analyses: two exploratory aims will investigate correlations between the brain imaging outcome measures described above. 1) Previous studies in animals have shown that ethanol exposure is associated with an up-regulation of the dynorphin/kappa receptor neurotransmission [15]. In addition, it has been shown that kappa receptor stimulation reduces stimulant-induced dopamine release [16]. Thus, we will explore the hypothesis that low kappa receptor BP is associated with low pre-synaptic dopamine release. 2) We will obtain measures of dopamine release obtained with PET and changes in blood oxygenation using fMRI in each subject. Thus, the goal of this exploratory aim will be to examine both pre-synaptic dopamine transmission and fMRI activation in the same subjects, and to test the hypothesis that blunted dopamine release in the ventral striatum correlates with decreased activation to the MID task.